CASE MANAGEMENT IN NIDDM

To demonstrate that it is possible to lower blood sugar levels in type II diabetes using an approach called nursing case management and thereby reducing the risk of complications.